Development of a diagnostic platform for PTSD blood biomarkers

PROJECT SUMMARY
Post-traumatic stress disorder (PTSD) is a disorder of stress reactivity with clinical manifestations that are
evident when patients are triggered following exposure to a traumatic event. Impaired sensitivity to
glucocorticoids (GCs) and alterations in peripheral blood mononuclear cell (PBMC) gene expression profiles,
including genes implicated in GC signaling and inflammatory cytokine production, are at the crossroads of
peripheral and central susceptibility pathways and represent promising PTSD biomarkers. However, their small
case-control effect sizes have been a significant barrier to the development of actionable diagnostic
biomarkers for the disorder. Notably, such studies have been performed post-trauma under baseline conditions
and do not fully recapitulate the molecular response to adverse pathophysiological triggers, such as exposure
to stress hormones. We developed a new in vitro model that sensitizes PBMCs to the synthetic GC,
dexamethasone (DEX). Our model captures differences between individuals in sensitivity to GCs and
significantly amplifies PTSD gene expression effect sizes into a range that may facilitate the development of
actionable biomarkers. Still, cell type-specific differences in GC sensitivity have not been fully appreciated in
PTSD and represent an important step forward for the development of translatable biomarkers and
therapeutics. Here, we propose to combine our in vitro model with single-cell cellular indexing of
transcriptomes and epitomes by sequencing (CITE-seq) and chromatin immunoprecipitation (ChIP)-seq to
investigate the single-cell transcriptional responses to GC activation in PTSD. Specifically, we will investigate
Aim 1) cell type-specific transcriptional differences using the CITE-seq approach on vehicle and DEX treated
PBMCs derived from trauma-exposed combat veterans with PTSD(+; n=20) and without PTSD(-; n=20), as
well as healthy trauma-free participants (HC; n=20). In doing so, we will study ~600,000 single cells (~5,000
cells per condition for each individual). Flow-cytometry will quantify the density and proportion of GR
expression on five major immune cell types. Because the GR has site-specific DNA binding activity that differs
between cells and conditions, we will Aim 2) perform anti-GR ChIP-seq data on five major immune cell subsets
to identify genome-wide, cell type-specific GR binding sites. Integrating CITE-seq, GR expression and ChIP-
seq across DEX exposed immune cell subsets will provide more nuanced and accurate insights into the
cellular and molecular perturbations associated with altered GC sensitivity in PTSD. We have already
measured genome-wide RNA-seq in bulk PBMCs treated with DEX and uncovered robust transcriptional
differences distinguishing PTSD+ from PTSD-. Successful completion of this proposal will uncover cell type-
specific transcriptional responses that will serve as definitive guides for the development of biomarkers for
PTSD stress responsivity, vulnerability and resiliency.

Public health relevance
PROJECT NARRATIVE Understanding variability in stress-responses and heterogeneity in susceptibility to posttraumatic stress disorder (PTSD) has major implications for the development of translational biomarkers. To gain more nuanced and accurate insights into differential stress responses in PTSD, the current proposal combines a novel in vitro model with cutting-edge sequencing technology to study transcriptional differences in sensitivity and responsivity to glucocorticoids in PTSD at single-cell resolution. Results from this study will elucidate cell specific transcriptional changes associated with individual differences in glucocorticoid sensitivity in veterans with PTSD that will significantly amplify case-control effect sizes, which represents a critical step for the development of actionable biomarkers.